Office for Clinical Research

The overall objectives of the University of Virginia (UVA) Cancer Center's Office of Clinical Research (OCR) are to provide a central clinical research infrastructure to: • Facilitate the activation and administration of research clinical studies • Assist Cancer Center Principal Investigators and clinicians in the screening and enrolling of patients on clinical research studies • Monitor compliance with all regulatory aspects of clinical trials in conjunction with the Protocol Review Committee, IRB, state, and federal guidelines • Provide a training and education program for all Cancer Center staff involved in clinical research studies • Provide support for internal and external quality assurance audits • Communicate the availability of clinical research studies to Cancer Center physicians, referring physicians, and the community • Recommend, develop, implement, and maintain state-of-the-art information systems to support the workflow, data sharing, analyses, and reporting requirements of cancer clinical research studies • Train users on the Forte Research Systems, OnCore™ clinical research management system

Public health relevance
RELEVANCE (See instructions): Rigorous clinical research that meets the highest scientific and regulatory standards requires a robust infrastructure to support the opening and management of clinical trials. That is the mission of the OCR.